Developing Evidence to Improve Racial and Ethnic Diversity in the MD-Scientist Workforce

The physician-scientist workforce persistently fails to reflect the racial and ethnic composition of both the United
States' (U.S.) general population and medical schools. There is growing attention in medical education to the
importance of professional identity formation, defined as the development of values, beliefs, aspirations, and
sense of affiliation aligned with the norms of the profession. There is evidence that experiences during medical
school play a critical role in shaping physician-scientist professional identity formation, and that these
experiences differ between underrepresented in medicine (URiM) and non-URiM students. Yet little is known
about training practices and organizational characteristics of medical schools with the greatest success in
equitable physician-scientist professional identity formation among URiM medical students, including Blacks,
Hispanic/Latinx Americans, and Native Americans.
We propose a multi-stage mixed methods study to identify the training practices and organizational
characteristics of MD programs with greatest success in equitable physician-scientist professional identity
formation among URiM single-degree medical students, relative to non-URIM students. This objective will be
achieved through the following specific aims: 1) use data from the Association of American Medical Colleges
[AAMC] Graduation Questionnaire [GQ] to identify MD programs which consistently demonstrate greatest and
least success in equitable physician-scientist professional identity formation among URiM medical students
relative to non-URiM students; 2) develop hypotheses about best practices and organizational characteristics for
promoting equitable physician-scientist professional identity formation by conducting in-depth qualitative
interviews at MD programs demonstrating the greatest and least success in equitable physician-scientist
professional identity formation, and; 3) evaluate associations between practices and organizational
characteristics identified in Aim 2 and consistent equity in physician-scientist professional identity formation
through a national survey to identify best practices and characteristics that are broadly applicable to U.S. MD
programs.
This study is significant because it will provide information that can inform efforts to enhance the racial and ethnic
diversity of the physician-scientist workforce. Our primary outcome of institution-level equity in physician-scientist
development between URiM and non-URiM students is innovative and practical. Whereas rates of physician-
scientist development may differ between MD programs, due to characteristics such as research intensity of the
school, disparities in rates of physician-scientist development between non-URiM and URiM students within MD
programs signal potential issues regarding egalitarian distribution of resources and discriminatory practices.
Dissemination will take the form of scholarly publications and real-world communications (toolkit, website,
podcasts, etc.) in partnership with high-profile national organizations, e.g., AAMC, for maximal impact.

Public health relevance
Although increasing racial and ethnic diversity in the biomedical research workforce is a national priority, there is a dearth of evidence-based strategies to promote diversity. To address this important knowledge gap, we propose utilizing a positive-deviance methodology to identify strategies to promote the development of physician- scientist professional identity among medical students historically underrepresented in medicine by race/ethnicity. Results from our study have the potential to influence how medical schools train minoritized physician-scientists to build a more diverse biomedical research workforce.